Structure and function of novel prokaryotic DNA transposases

We have been investigating Insertion Sequence (IS) movements in multidrug resistant bacteria with a focus on carbapenemase-producing Enterobacteriaceae (CPE). We have previously analyzed the genomic contexts of ISs in several clinical and surveillance CPE isolates from the NIH Clinical Center, using target site duplications (TSDs) and their distribution patterns as guides, and discovered that a large fraction of plasmid reorganizations result from IS26 intramolecular replicative transpositions, including replicon fusions, DNA inversions, and deletions (1,2). We are interested in learning about the mechanisms behind these DNA rearrangements, and are currently investigating the biochemical and biophysical properties of a variety of recombinantly expressed replicative transposases.

Another result that emerged from our analysis of CPE isolates from the NIH Clinical Center was the recognition of the central role played by Insertion Sequences that transpose using the so-call "copy-out-paste-in" mechanism (1,2). Demonstrating the importance of this pathway was our discovery of how ISApl1, a copy-out-paste-in transposon, facilitated the emerge of colistin resistance by forming a tandemly repeated composite transposon (3). Despite its central importance, there is no current mechanistic information available regarding how this process works. Recently, we have solved several X-ray structures of a transposase from the IS256 family that is mobilized by this pathway (the ISCth4 transposase) in complex with various DNA substrates (4). The results show that it forms an unusual asymmetric dimeric transpososome in which an array of N-terminal domains binds a single transposon end whilst the catalytic domain moves to accommodate its varying substrates. This asymmetric arrangement explains the unusual asymmetric cleavage of the transposon ends that is a hallmark of copy-out-paste-in transposition.

1. He, Hickman, Varani, Siguier, Chandler, Dekker, and Dyda (2015) Insertion Sequence IS26 reorganizes plasmids in clinically isolated multidrug-resistant bacteria by replicative transposition. mBio 3, e00762-15.
2. He, Chandler, Varani, Hickman, Dekker, and Dyda (2016) Mechanism of evolution in high-consequence drug resistance plasmids. mBio 6, e01987.
3. Snesrud, He, Chandler, Dekker, Hickman, McGann, and Dyda (2016) A model for transposition of the colistin resistance gene mcr-1 by ISApl1. Antimicrob. Agents Chemother. 60, 6973.
4. Kosek D, Hickman AB, Ghirlando R, He S, Dyda F (2021). Structures of ISCth4 transpososomes reveal the role of asymmetry in copy-out/paste-in DNA transposition. EMBO J 40, e105666. https://doi.org/10.15252/embj.2020105666